Molecular mechanism of regulation and activation of membrane proteins in native membrane milieu

Project Summary/Abstract
Heterogeneity in spatial and temporal dimensions is a hallmark of mammalian cell membranes. This partitions
cellular membranes into distinct nanodomains distinguished by specific lipid-lipid or lipid-protein interactions.
These nanodomains provide a dynamic, spatiotemporally organized platform for membrane-localized regulation
of critical signaling pathways, imparting unique organization and bioactivity to the signaling proteins (and their
effectors/substrates) that are associated with or embedded in them. This regulation of membrane proteins by their
endogenous microenvironment is fundamental to critical biological functions and is often impaired in diseases
such as cancer, neurodegeneration, and immune disorders.
Despite the significance of the native membrane milieu in modulating membrane protein functions, there is
a scarcity of experimental approaches for studying membrane proteins in their native lipid environment with
simultaneous spatial, temporal, and molecular resolution. Motivated by this inherent challenge, my goal is to
develop an experimental platform to understand the hierarchical and functional organization of membrane
proteins in an endogenous cell membrane environment with precise spatial and molecular resolution. I will use
an amphipathic styrene-maleic acid copolymer (SMA and its chemical analogs) to excise circular patches of the
cell membrane, generating ~10-15 nm-sized “native nanodiscs”. SMA-encapsulated membrane proteins of
interest are surrounded by an annular ring of endogenous lipids and interacting proteins, preserving their local
membrane microenvironments and offering unprecedented spatial resolution. Following further enrichment and
purification, I will use single-molecule TIRF microscopy, native mass spectrometry, lipidomics and proteomics,
functional assays, and structural studies to investigate the biophysical and biochemical properties of these SMA-
encapsulated membrane proteins within their endogenous environment.
I will study two clinically relevant membrane/membrane-associated proteins using this approach – (1) KRas,
a small GTPase that is a prominent oncogene with >95% mutation frequency in pancreatic cancers, and (2) Trk
family receptor tyrosine kinases that bind neurotrophins and are central to neuronal development, differentiation,
and survival and are implicated in pain perception. I will address outstanding questions about the structural and
functional organization of these proteins on the native membrane, how the spatially enriched proteome and
lipidome around these proteins regulate their organization, how that influences the biological activity of these
membrane proteins, and ultimately how that impacts downstream signaling. The direct involvement of protein-
lipid interaction and dynamics in several diseases necessitates a quantitative understanding of membrane proteins
in their native membrane milieu. My proposal outlines a general experimental pipeline with a broad and
transformative impact on understanding the regulation and activation of membrane proteins in the context of their
endogenous environment with precise spatial and molecular resolution.

Public health relevance
Project Narrative I will develop an experimental pipeline that is broadly applicable to study the molecular mechanism of regulation and activation of membrane/membrane-associated proteins in the context of their endogenous environment, by extracting them while retaining an annular ring of their local protein and lipid interactome (native nanodiscs). These native nanodiscs can be used in several biophysical and biochemical analyses to understand the structural and functional organization, spatially-enriched endogenous proteomic and lipidomic environments, and ultimately bioactivity of target membrane proteins embedded in them. I propose to apply this pipeline and downstream analyses to investigate (1) a small, clinically relevant GTPase that is a hallmark oncogene, and (2) a receptor tyrosine kinase family that is critical for neuronal survival and development and plays a crucial role in pain perception.